Longitudinal Study of HIV and Aging in Brazil

PROJECT SUMMARY
This study will investigate the epidemiology and immunology of neurocognitive symptoms of post-acute
sequelae of COVID-19 (PASC, or “long COVID”) in older people living with HIV (PWH). Cognitive decline
remains a common and important complication of aging with HIV and is associated with adverse outcomes
including frailty, poor quality of life, disability, and death. Lasting neurocognitive symptoms of COVID-19 may
be more common in older PWH given their risk factors for PASC as well as differences in underlying immune
senescence and inflammation. However, the clinical burden and immunologic phenotypes of neurocognitive
symptoms of PASC in older PWH have not been described to date. This information is particularly needed in
low- and middle-income countries where heterologous SARS-CoV-2 vaccinations and high COVID-19
incidence were observed. This study will examine (1) the clinical phenotypes and determinants of
neuropsychiatric outcomes measures among older PWH with PASC and will seek to determine (2) the
immunologic and clinical profiles of older PWH with discordant immunologic and clinical sequelae of SARS-
CoV-2 infection. A nested, cross-sectional study using the rich baseline clinical data and biospecimens of the
NIA-funded Longitudinal Study of HIV and Aging in Brazil will collect detailed data of COVID-19 infections,
symptoms, and prior vaccination to identify older PWH with PASC. A cohort of 300 participants with and
without PASC will undergo additional neurocognitive testing to describe specific cognitive phenotypes in older
PWH with and without PASC. Further, we will use stored biospecimens to identify older PWH with poor
immunologic response to COVID-19 infection and vaccination as well as those with and without PASC to
examine differences in adaptive immune senescence and systemic measures of neuroinflammation to identify
clues of the immunologic mechanisms contributing to adverse COVID-19 outcomes in this population. Located
in one of the epicenters of the COVID-19 pandemic and led by experts in HIV and COVID-19 epidemiology and
immunology, this study will offer novel and needed insights into a critical complication of the COVID-19
pandemic in PWH.

Public health relevance
PROJECT NARRATIVE Many people who survive COVID-19 develop lasting symptoms, including cognitive decline, difficulty focusing, and fatigue. Adults living with HIV are at increased risk of cognitive decline as they age and may be at increased risk for COVID-19. We have little knowledge of lasting neurocognitive symptoms following COVID-19 in older people with HIV, particularly in low- and middle-income countries. Understanding the frequency, risk factors, and immunology of lasting COVID-19 symptoms in older adults with HIV is important to plan interventions to improve their quality of life and long-term outcomes.